EphA2 signaling in atherosclerotic fibroproliferative remodeling

Project Summary
The Eph family of receptor tyrosine kinases, the largest in the mammalian genome, and their ephrin ligands
critically influence inflammation in a variety of pathological conditions. Our work provided the first description of
EphA2 expression in multiple cell types in the atherosclerotic plaque, and we recently demonstrated that EphA2
deletion reduces atherosclerotic plaque formation associated with diminished plaque inflammation. Surprisingly,
EphA2 deletion also reduced progression to advanced atherosclerotic disease with diminished plaque smooth
muscle content. Phenotypic modulation of smooth muscle cells from a contractile to a synthetic phenotype drives
their accumulation during plaque development, and smooth muscle cells show enhanced EphA2 expression
during phenotypic modulation both in vitro and in vivo. Our preliminary data show that matrix remodeling that
promotes fibronectin-dependent integrin signaling critically regulates EphA2 expression during phenotypic
modulation, whereas blunting EphA2 expression limits fibronectin matrix deposition in vivo and in vitro. Taken
together, these data suggest a dynamic interplay between EphA2 and matrix remodeling that critically regulates
the smooth muscle matrix deposition.
In addition to matrix deposition, we also demonstrated a critical role for EphA2 expression in smooth muscle
mitogenic signaling (ERK1/2, AKT) and proliferation both in vitro and in atherosclerotic plaques in vivo. While
EphA2 ligation by ephrinA1 elicits multiple aspects of EphA2's atherogenic proinflammatory responses, our
preliminary data show that EphA2 ligation reduces smooth muscle proliferation. Conversely, EphA2 can also
signal in a ligand-independent state, which promotes cell proliferation and migration in cancer models, and we
observed an increase in EphA2 ligand-independent signaling (Ser897 phosphorylation) during smooth muscle
proliferation in vitro and at sites of smooth muscle phenotypic modulation in vivo. However, the mechanisms
regulating EphA2's differential ligand-dependent and ligand-independent mitogenic signaling remain virtually
unexplored. Therefore, we hypothesize that dynamic interplay between EphA2 expression and matrix
remodeling in the atherosclerotic plaque drives smooth muscle invasion and fibroproliferative remodeling through
activation of EphA2 ligand-independent signaling. To test this hypothesis, we will characterize the dynamic
interplay between EphA2 expression and matrix composition using both cell culture models and smooth muscle-
specific deletion of fibronectin and fibronectin-binding integrins (Aim 1), we will determine the mechanisms by
which EphA2 signaling affects smooth muscle phenotype (Aim 2), and we will assess the role of EphA2 cell-type
specific expression and signaling in atherosclerotic fibroproliferative remodeling using novel EphA2 conditional
knockouts and inhibitors of EphA2 ligation and kinase activity. Successful completion of these Aims will identify
a novel mechanism to selectively reduce plaque-associated inflammation while promoting smooth muscle-
dependent stabilization of the fibrous cap.

Public health relevance
The interplay between inflammation and fibroproliferative vascular remodeling critically regulates the vulnerability of atherosclerotic plaques. Our research identifies members of the Eph/ephrin family of guidance molecules as novel players in these process, regulating ligand-dependent inflammation and ligand- independent smooth muscle fibroproliferative remodeling. Targeting these differential signaling responses therapeutically may allow for simultaneous inhibition of inflammation and promotion of fibroproliferative remodeling.